B-SAFE: A Trauma-Informed Early Intervention Targeting Sleep and Adjustment Among Children in Foster Care

PROJECT SUMMARY
Children in foster care (FC) evidence poorer developmental, physical and mental health
outcomes than even the poorest children in the U.S. and unmet need in this fragile group is
extraordinarily high. Of the small number of early intervention programs demonstrated as
effective for this population, most are directed at infants and young children. However, more
than half of the children entering FC each year are older than 5 years, a time when capacity for
and expectations of self-regulation are greater, but history of maltreatment/trauma is likely more
extensive. Sleep disturbance is one of the most well-recognized consequences and enduring
sequela of early adversity/trauma that creates a feedback loop through which arousal/anxiety is
amplified, self-regulation is undermined, and biological rhythms are altered. Mounting evidence
reveals the presence of significant sleep disruption among a majority of children in FC, which is
closely associated with elevated mental health problems. Sleep disturbances are often worst in
the initial weeks/months of a new foster placement. Early intervention programs targeting sleep
might therefore prevent a cascade of associated negative outcomes. Our research team, with
unique expertise in pediatric sleep, childhood maltreatment, attachment, and the delivery of
foster care interventions, will use a trauma-informed framework to adapt cognitive-behavioral
therapy for pediatric insomnia for school-aged children recently placed in a new foster home.
Aligning with the goals of RFA-MH-18-706, we propose a 3-year, multi-phase study to finalize
and test a brief, home-based early intervention program, called Bolstering Sleep and
Adjustment in Foster Environments (B-SAFE). B-SAFE's target mechanisms are informed and
supported by a wealth of research showing reductions in children's nighttime anxiety/arousal
and greater parental support around bedtime/sleep routines to correspond with improvements in
children's sleep, emotional and behavioral health. Phase 1 will include input and feedback from
our FC agency partners, expert consultants, and several pilot families in order to finalize the B-
SAFE manual, materials, and procedures. In Phase 2, we will conduct a randomized, controlled
trial among N=60 new families; 30 will start the B-SAFE program within the first month of a new
child placement, and 30 will serve as waitlist (WL) controls. Several months later (Phase 3), WL
families will complete the B-SAFE program for comparison with the experimental group to
inform optimal intervention timing. Feasibility and child-based outcomes including sleep health,
emotional/behavioral regulation, and biological rhythms will be examined via objective and
subjective measures, and target engagement will be confirmed. In addition to supporting a
larger effectiveness trial, findings will directly inform dissemination efforts including training
practitioners, alternative delivery settings, and potential adaptation for other trauma-exposed
child populations, for whom evidence-based sleep interventions do not exist.

Public health relevance
PROJECT NARRATIVE Sleep disturbances are pervasive and impairing among children in foster care but not a single prevention or intervention program for this fragile group targets sleep health. Poor sleep undermines effective self-regulation and stable biological rhythms, amplifying the negative impacts of early adversity/trauma on children's acute and long-term functioning. Consistent with evidence that optimizing sleep is critical for trauma recovery, we will adapt cognitive-behavioral treatment for pediatric insomnia, an efficacious intervention for various clinical and non-clinical child populations, for home-based delivery among children recently placed in a new foster home and evaluate initial efficacy, feasibility and target engagement.